Research Education Component

PROJECT SUMMARY – RESEARCH EDUCATION COMPONENT (REC)
The Mayo ADRC Research Education Component (REC) will offer a comprehensive training program to
equip the next generation of clinicians and investigators with the necessary skills to attack the complexities
of Alzheimer’s Disease and related dementias (AD/ADRD). The multidisciplinary expertise of the faculty of
the Mayo ADRC REC encompasses all facets of AD/ADRD research, including clinical and basic science,
neuropsychologic, neuroimaging, genomics, biofluid, neuropathologic, digital, and bioinformatics compo-
nents. The REC faculty have expertise not only in Alzheimer’s disease, but in other dementias encompassed
by the ADRD definition, such as Lewy body dementia/Lewy body disease, frontotemporal lobar degenera-
tion/frontotemporal dementia, and cerebrovascular disease/vascular dementia, as well as multi-etiology de-
mentia resulting from combinations of these. Training will be provided via lectures and courses, group dis-
cussions, seminars and workshops, face-to-face interactions with Clinical Core research participants, as
well as through laboratory work and experiences which leverage biofluids, genetic data, and tissue specimens
from ADRC Cores. In collaboration with the RECs of Wisconsin, Massachusetts, and UCSF ADRCs, we will
offer our REC scholars career development opportunities that include site visits, seminars, and networking
opportunities. Mayo Clinic, Mayo ADRC, and the REC are committed to building an environment where peo-
ple from all backgrounds, cultures, and experiences can be and bring their authentic best selves. As such,
we will prioritize training of scholars from underrepresented groups to inspire and support individuals to pur-
sue careers in AD/ADRD research.